UCSF-Bay Area Center for AIDS Research

PROJECT SUMMARY FOR OVERALL CENTER FOR AIDS RESEARCH (CFAR)
Over the past four decades, UCSF and its affiliates have worked persistently on the domestic and global
HIV/AIDS crisis, including in treatment, prevention, cure efforts, advocacy, co-infections and comorbidities. The
now renamed UCSF-Bay Area Center for AIDS Research (CFAR), embedded at UCSF but with affiliate
partners, has served as a cornerstone organization to coordinate these efforts and advance HIV research
across our campus, city and beyond. Through its scientific leadership, multiple Mentoring programs, pilot
grants in the Developmental Core, Scientific Cores, community engagement, efforts towards diversity, support
of early-stage investigators (ESIs), support of underrepresented minority (URM) investigators, and global
programs, the UCSF CFAR has sought to create a vibrant, nimble, and responsive HIV research enterprise.
The newly restructured UCSF Bay Area CFAR, under new leadership since July 2019, will continue its
oversight by the 1) Administrative Core (including coordinating communications, monitoring and evaluation,
events and community engagement) and its foundation of the 2) Developmental Core (including our acclaimed
Mentoring programs and a new mentoring program designated for URM researchers). The UCSF-Bay Area
CFAR will then reconfigure our expertise into three other Scientific Cores centered on 3) Basic and
Translational Science (Immunology, Pharmacology, a new focus of Bioinformatics); 4) Clinical Research
(including continued support of our dynamic SCOPE HIV cohort – a cohort that has been highly productive in
fostering pathogenesis and translational research; a new Participant Referral Service from the diverse publicly-
insured Ward 86 HIV Clinic to enhance diversity in SCOPE, other clinical cohorts and CFAR investigator-led
studies; and continued support of Specimen Processing and Banking); and a new focus on 5) Bio-Behavioral
Research (with a new Prevention cohort; a Substance Use Research Program; and a Biomarkers of Behavior
Program featuring a laboratory which will provide objective metrics of adherence and substance use). The five
Cores will be supplemented by two Scientific Working Groups (in Housing and Intersectionality) focused on
efforts to address structural determinants of health and grow expertise in methods to fundamentally advance
goals to End the HIV Epidemic. Finally, cross-cutting areas across the entire CFAR include health equity and
community engagement, training and career development, and international work. Each Core and Scientific
Working Group will be expected to address each of these three cross-cutting areas in their work.
In this renewal of the UCSF CFAR, we will continue to advance multidisciplinary, cutting-edge research
in treatment, prevention, pathogenesis, cure and persistence, HIV pharmacology, clinical care paradigms,
comorbidities and coinfections, adherence, structural determinants, and other relevant research on HIV/AIDS
as we exit the first four decades of the HIV epidemic and work towards bringing it to an end.

Public health relevance
PROJECT NARRATIVE The restructured UCSF-Bay Area CFAR is dedicated to promoting multidisciplinary research addressing cutting-edge questions in HIV/AIDS biology, treatment, and prevention. This approach from UCSF has led to breakthrough discoveries advancing patient care and providing new approaches to curbing the HIV pandemic both locally and internationally. CFAR is also committed to supporting the next generation of HIV researchers, international research, health equity, and community engagement, all of which are critical for truly ending the HIV epidemic.